Community-engaged environmental monitoring for biowaste treatment transitions

PROJECT SUMMARY/ABSTRACT
The communities in Sampson and Duplin Counties, in North Carolina, who are largely Black,
Indigenous, and People of Color (BIPOC), have had their environmental quality disproportionately affected
by long-existing concentrated animal feeding operations (CAFOs). A new initiative of large-scale pork
industry to produce renewable energy from animal waste at CAFOs has been well-supported by North
Carolina government and is expected to grow significantly in the coming years. Although the affected
communities are concerned about the additional adverse impact of new swine waste-to-energy (SWE)
operations, little data exist to provide any knowledge on the environmental health impact of SWE operations.
The Sampson and Duplin communities have identified a time-sensitive need to systematically assess their
current environment and public health status before the AlignRNG SWE project becomes fully operational.
Our study goal is to address the communities’ needs for baseline data with an assessment of the
environmental and public health landscape of the Sampson and Duplin Counties communities prior to
widespread SWE transitions. We will conduct a comprehensive longitudinal environmental health monitoring
(i.e., air, water, and health) with a community participatory research approach, leveraging existing resources,
and through a partnership with a trusted community action group from other RTI-leading/collaborating
studies in the same community. We will refine and improve technical approaches that previous studies,
including ours, have developed and apply to this unique environmental challenge for understudied,
disadvantaged population. Those approaches include co-production of study with active involvement from
community members to identify and develop processes that meet their needs, low-cost sensor network to
collect high-resolution longitudinal air quality data, longitudinal data of private well water quality and health
and quality of life, and low-burden ecological momentary assessment tool. This study will provide all
stakeholders (i.e., the study community, agriculture industry, researchers, state officials, and policy makers)
a comprehensive baseline analysis of exposure and health status in this under-assessed community facing
SWE transition. The study community and RTI researchers will co-produce data collection and summary
methods that will also be used in future assessment phases to understand the SWE transition affects. The
study findings, data, and processes from this study will be shared with other community groups that have
similar needs but few resources for assessments and guidance to address their environmental health
challenges and North Carolina Department of Health and Human Services’ NC Environmental Public Health
Tracking Program for broader dissemination.

Public health relevance
PROJECT NARRATIVE The proposed study aims to address the need to conduct a time-sensitive baseline environmental quality and health assessment in the communities of Sampson and Duplin Counties, North Carolina, before the completion of an impending large-scale biogas production project, so that future environmental impact assessments can provide accurate data-driven knowledge that help environmental management and public health policy makers develop strategies that prioritize public health benefit. This study will collect a new comprehensive dataset at high spatial and time resolution for air, drinking water, and health symptoms over a year to characterize the variability in environmental quality and association between exposure and health outcomes. The study findings, data, tools, refined and improved technical approaches, and research processes designed for this Black, Indigenous, and People of Color (BIPOC), agricultural community will be shared with other community groups that have similar needs but few resources and North Carolina Department of Health and Human Services’ NC Environmental Public Health Tracking Program for broader dissemination and future study design.